Southern Center for Maternal Health Equity

This project will provide a strong paradigm for implementing multilevel programs to prevent maternal
complications and improve access to care for Black birthing people, pregnancies in the Gulf South, and those
living in maternity care deserts, consistent with the IMPROVE initiative’s goal of reducing preventable causes
of maternal deaths and improving health for women before, during, and after delivery.

Public health relevance
Addressing the ongoing maternal health crisis in this country is not possible without centering Black birthing individuals. Nowhere are racial inequities and poor maternal health in starker relief than in Louisiana and Mississippi, which consistently rank last in the country on several health indicators. Urgently needed are interventions at multiple levels, coupled with sustained implementation of programs and policies that have been proven to promote pregnancy health. The Southern Center for Maternal Health Equity is a partnership among the National Birth Equity Collaborative (NBEC), Tulane University, and Ochsner Health System. It joins NBEC’s focus on optimizing Black maternal health through establishing the community as the experts on their health; Tulane’s technical expertise in epidemiology, translational research, and health policy and economics; and Ochsner’s depth in clinical and outcomes research and community-rooted network of clinical care. The overall objective of the Center is to improve maternal health through testing community-prioritized and co- developed strategies. A research center will be established, embedded within ongoing community partnerships and the existing research, training, and outreach infrastructure, to build and strengthen maternal health. The center’s overarching focus is addressing root causes (bias, insufficient access to care, health and social policy) of maternal morbidity and mortality, with a focus on Black women in the Gulf South. The overall research theme is assessing implementation of existing evidence-based strategies and building the evidence base for and translation of novel strategies that drive innovative models of care tailored to the community priorities and needs. The objective of the Research Projects is to assess interpersonal, health system, and policy interventions that combine to create a multilevel approach to advancing maternal health, and evaluate these strategies from cross-cutting perspectives, including cost-effectiveness, clinical care, and health equity. This will be achieved through conducting three research projects: a trial in a large health care system of a multifaceted behavior change intervention to reduce biased treatment (interpersonal level; RP1); adapting and evaluating an enhanced remote monitoring package in low maternity care access areas (health care provision level; RP2); and assessing the effects of Medicaid postpartum extension legislation on maternal health (policy level; RP3). The objective of the Training Core is to provide innovative and transdisciplinary training for early career scholars, aimed at developing a research workforce that can reduce maternal morbidity and mortality locally, regionally, and nationally. The objective of the Community Partners Core is to incorporate community priorities, vision, and expertise in all areas of the project, and to return results and benefits directly to impacted communities. The transdisciplinary research and training made possible by this U54, in collaboration with the other awarded centers and the data and implementation hubs, will contribute to innovative approaches that will reduce maternal deaths and severe maternal morbidity in communities most at risk.